RhoFED AA-SCCC

PROJECT SUMMARY/ABSTRACT
The cooperative agreement funded by this Funding Opportunity Announcement establishes an Asthma and
Allergy Statistical and Clinical Coordinating Center (AA-SCCC), which will further NIAID’s mission to support
clinical research aimed at developing new or improved strategies to treat or prevent allergic diseases and
asthma. The objective of the AA-SCCC is to provide excellent and efficient coordination of the following
services: protocol development, study initiation and management, statistical design and analysis, and
biological specimen repository management. To accomplish these objectives, Rho aims to (1) provide staff
experienced in research conducted by NIAID-supported research networks and to organize these staff in an
administrative structure that manages resources efficiently, is responsive to the needs of the research
networks and NIAID, and facilitates communication and collaboration; (2) provide experienced scientists and
statisticians who, in collaboration with clinical investigators and NIAID officials, design and analyze studies
across the full scope of research; (3) facilitate the development, review, and revision of research protocols and
protocol-related documents through dedicated protocol teams; (4) provide study initiation and study
management functions that are required for the efficient, valid, and ethical conduct of studies; (5) continuously
monitor the accuracy and completeness of research data; (6) help ensure patient safety by providing high-
quality adverse event surveillance and Data and Safety Monitoring Board (DSMB) reports; (7) provide for
secure storage of biospecimens, along with their distribution for innovative mechanistic research; and (8)
effectively collaborate with the other components of the NIAID clinical research program, e.g. the NIAID
Regulatory Management Center (RMC), the Clinical Data and Safety Management Center (CDSMC), the
Clinical Site Monitoring Center (CSMC), and the Clinical Products Center (CPC).
Based on more than 25 years of experience coordinating all aspects of clinical research in asthma and allergic
diseases, we will use our current technology infrastructure, combined with new and innovative techniques to:
streamline and automate processes; provide easy access to data for DAIT, clinical investigators, and other key
research stakeholders; allow for flexibility of staffing and resource sharing; standardize processes and
methodologies across research networks where practicable; and continue to provide the flexibility necessity to
meet the changing demands of this dynamic research program.

Public health relevance
PROJECT NARRATIVE This cooperative agreement funds a coordinating center that provides investigators across the United States with the tools, expertise, and support to conduct effective clinical research studies in allergic diseases and asthma. By ensuring consistency and quality of asthma and allergy research across multiple research sites, we can help provide new insights into management of these conditions and into biologic mechanisms of allergic disease development. These insights can lead to new treatment or prevention strategies that will improve the lives of people living with these conditions.